Cytokine regulation of RA synoviocyte phenotype

In rheumatoid arthritis (RA) inflammatory cytokines produced by synovial (joint) cells drive disease
pathogenesis by activating cells in inflamed joints and promoting recruitment of immune cells. The long-term
goals of this project are to understand how cytokines and inflammatory factors expressed in RA synovium
activate cells to drive disease pathogenesis, and to elucidate mechanisms that regulate production of
pathogenic cytokines in the context of RA synovitis. An associated goal is to use this knowledge to develop
safer and effective therapies that target disease-related mechanisms of cytokine production and function.
This project has focused on two key synovial cell types important in RA pathogenesis, fibroblast-like
synoviocytes (FLS) and synovial macrophages (Ms; previously termed type A synoviocytes). These two
cell types interact closely in RA synovium. RA synovial macrophages express gene signatures reflecting
inflammatory NF-B and Jak-STAT signaling and produce inflammatory cytokines. RA FLS produce
cytokines and inflammatory factors such prostaglandins (PGs), and exhibit tissue-destructive properties.
In the previous project period, we defined a role for FLS in regulating inflammatory M phenotype
by modulating TNF responses to suppress IFN-stimulated gene (ISG) expression while promoting
synergistic expression of inflammatory genes and growth factors that in turn increased FLS invasive
behavior. A large fraction of the FLS-modulated TNF response in Ms was mediated by prostaglandin E2
(PGE2) and accordingly was almost completely recapitulated by exogenous PGE2, working via G protein-
coupled receptors (GPCRs) and cAMP signaling. PGE2-cAMP signaling suppressed TNF and ISG
expression, but cooperated with TNF to induce distinct inflammatory `synergy genes'.
Strikingly, the gene signature commonly induced by FLS+TNF and PGE2+TNF was expressed in
RA synovial macrophages, including a subset identified by single cell RNA sequencing that also expresses
inflammatory and IFN signatures. These results highlight the importance of GPCR and downstream cAMP
signaling in the RA synovial macrophage phenotype. GPCR-cAMP signaling in RA synovium can be
activated by various factors including PGs, acidosis and neuropeptides. Thus, it is important to understand
the impact of GPCR-cAMP signaling on macrophage inflammatory responses.
Our overarching hypothesis is that the impact of PGE2- and GPCR-cAMP signaling on macrophage
inflammatory responses can be selectively modulated to more effectively suppress TNF and ISGs, while
avoiding induction of potentially pathogenic `synergy genes' such as those expressed by RA macrophages.
In this project we will dissect signaling and chromatin-mediated mechanisms by which cAMP signaling
regulates inflammatory responses in human macrophages. We anticipate that our studies will provide
knowledge that can be used to shift GPCR-cAMP signaling towards increased suppression of inflammation.

Public health relevance
Macrophages and fibroblast-like synoviocytes (FLS) are cells present in inflamed joints that have been implicated in the pathogenesis of rheumatoid arthritis (RA). The long-term goals of this project are to understand how cytokines and inflammatory factors expressed in RA joints (synovium) activate these cells to drive inflammation and the disease process. This project will investigate how signaling pathways activated in RA synovium regulate macrophage inflammatory responses to gain knowledge that can be used to increase anti-inflammatory signaling and more effectively treat patients with rheumatoid arthritis.